The Role of IL-33 in Chronic Itch

PROJECT SUMMARY
Chronic itch is debilitating symptom that severely limits quality of life and affects up to 20% of the population.
Despite this, there are no FDA-approved drugs specifically indicated for the treatment of chronic itch. Our current
understanding of chronic itch pathophysiology largely derives from studying inflammatory disorders such as
atopic dermatitis (i.e. eczema). However, how chronic itch arises in conditions that lack overt cutaneous
inflammation is poorly understood. Chronic pruritus of unknown origin (CPUO) clinically lacks such overt skin
inflammation, accounts for up to 40% of all chronic itch cases and lacks effective treatments. Improper barrier
function due to dry, aging skin has been proposed as a key driving factor of itch in CPUO, yet what may mediate
this is unknown. Notwithstanding this, our lab has brought recognition of this condition to the forefront in a series
of recent publications.
IL-33 is an `alarmin' released from keratinocytes upon damage or stress. Our preliminary studies show that IL-
33 is elevated in the sera of patients with CPUO compared to healthy controls. Further, a recent study showed
that IL-33 is required for the development of dry skin itch in a murine model that recapitulates several of key
aspects of CPUO. However, the mechanisms by which IL-33 promotes itch and how this process is regulated
remains poorly understood. IL-33 is a potent inducer of immune cell responses, however, we and others have
found that IL-33 can directly activate sensory neurons. Thus, in Aim 1, we will determine if IL-33 is a key mediator
of a direct epithelial-neuronal axis in dry skin itch using novel mice we have generated. The activity of IL- 33 is
dramatically enhanced upon cleavage by proteases. Our preliminary data suggest that the serine protease KLK7,
important for barrier homeostasis, promotes chronic itch through an unknown mechanism. In Aim 2, we will
evaluate if KLK7 cleaves IL-33, and enhances IL-33's capacity to induce itch. Our long-term goal is to determine
whether IL-33 and KLK7 are therapeutic targets in CPUO. The overall objective of our proposal is to identify the
role of IL-33 and KLK7 in promoting dry skin itch. Our central hypothesis is that IL-33 represents a direct
epithelial-neuronal mediator of itch that is regulated by KLK7. The rationale for this proposal is that once it is
understood how IL-33 and KLK7 promote itch in dry skin, these mechanisms can be harnessed to create effective
and novel therapies for CPUO and other dry skin-related conditions.

Public health relevance
PROJECT NARRATIVE Chronic itch is a highly prevalent, debilitating symptom that is difficult to treat due to a poor understanding of its pathophysiology. The goal of this proposal is to determine key mechanisms by which dry skin drives chronic itch of unknown cause, and unveil new therapeutic targets for this highly unmet need.